Improving diagnosis of High ICP in Cryptococcal meningitis (ICP-CRYPTO)

Abstract
Raised intracranial pressure (ICP) is a common complication of cryptococcal meningitis (CM), affecting around
half of patients, leading to increased morbidity and mortality. Lumbar punctures (LP) are used to diagnose
raised ICP, by measuring cerebrospinal fluid (CSF) opening pressure (OP), and to treat raised ICP by
therapeutic drainage of CSF. This reduces mortality but relief is often only temporary and high ICP frequently
recurs during treatment, requiring further repeat LPs, sometimes daily. LPs are invasive, often painful
procedures, and can lead to complications. A non-invasive test to identify patients with raised ICP would be
highly advantageous as it would help identify patients at risk of ICP-associated complications, and significantly
reduce the number of LPs performed purely for ICP monitoring reasons.
Retinal imaging technologies show great promise and are now routinely used to detect and monitor raised ICP
in other neurological conditions. These include Optical Coherence Tomography (OCT), which uses safe low-
power laser to produce high-resolution, cross-sectional images of the retina, allowing for very accurate
measurement of optic nerve swelling - a strong predictor of raised ICP; and fundoscopy, to identify retinal
vessel changes associated with raised ICP. With the development of low-cost, portable OCT machines and
lens adaptations that enable the use of mobile platforms for high-quality non-mydriatic fundoscopy, these
assessments are now much more accessible to non-ophthalmologists and in resource limited settings.
In this proof-of-concept translational proposal, we will evaluate whether mobile OCT and smartphone
fundoscopy can be used to identify high ICP in CM patients at diagnosis and during treatment, and which non-
invasive retinal imaging modality is better. To do this we will conduct a prospective cohort study in Kampala,
Uganda, enrolling patients with HIV-associated CM. We will perform serial OCT and smartphone fundoscopy
during inpatient treatment and compare these readings to opening pressure measured at LP. The proposal
draws together expertise in retinal imaging and OCT analysis from Dr. Mollan’s group in Birmingham, with the
clinical experience of a long-established and highly productive meningitis research collaboration between the
University of Minnesota and the Infectious Diseases Institute, Makerere University (Uganda).
This project has the potential to significantly impact the complex clinical care required to treat persons with
HIV-associated cryptococcal meningitis, particularly in resource-limited settings. Using mobile retinal imaging
as a non-invasive test for raised ICP would reduce the material resources, technical manpower, and possibility
of adverse events that are associated with performing LPs. By demonstrating proof-of-principle and technical
feasibility, the data from this R21 could then be leveraged into a larger diagnostic package of care used in a
R01-funded randomized control trial for novel treatments and management strategies to reduce ICP in CM.

Public health relevance
Narrative High intracranial pressure is a major source of morbidity and mortality in persons with advanced HIV disease and concomitant cryptococcal meningitis. This project seeks to study novel non-invasive retinal diagnostics using optical coherence tomography and smartphone fundoscopy to better diagnose and monitor intracranial pressure in Ugandans with cryptococcal meningitis. Non-invasive retinal diagnostics that can detect high intracranial pressure would improve care of HIV-associated cryptococcal meningitis in resource limited settings, and could be used as an endpoint in future clinical trials.